Elucidating the role of HIV-1 integrase in viral maturation

Project Summary
Maturation during the HIV life cycle consists of the viral Gag and Gag-Pol polyproteins undergoing sequential
proteolysis to create mature proteins, which organize into a functional viral core having the viral genomic RNA
(gRNA) condensed as a ribonucleoprotein particle (RNP) inside the mature capsid. Eccentric condensate (EC)
phenotypes, consist of the RNP localized outside the capsid, lead to loss of infectivity. The EC phenotype is
caused by antivirals that target both the viral CA and IN proteins; additionally, this has been shown in so-called
class II IN mutants. Recent work has shown that IN can bind to gRNA, indicating that IN has a critical role in
the maturation process and gRNA encapsidation. In accordance with previous findings, we hypothesize that IN
acts as a physical bridge between the gRNA and assembling CA. Consistent with this hypothesis, preliminary
data that we have collected suggests that IN binds to CA hexamers. Furthermore, cryoEM analyses indicate
that IN likely binds to the C-terminal domain (CTD) of CA, causing a shift in CTD-CTD organization as the
capsid assembles. Finally, RNPs purified from bona fide virions can be reencapsidated with recombinant CA
that is assembled de novo. Further investigations proposed in this F32 application aim to uncover a detailed
mechanistic binding scheme of IN and CA and will utilize complementary structural biology and biophysical
techniques. The results are expected to further our understanding of the maturation process of HIV and
possibly identify an attractive new target for antivirals.

Public health relevance
Project Narrative HIV maturation, specifically, the localization of viral genomic RNA (gRNA) inside the fullerene cone capsid, is a poorly understood process, creating a large gap in knowledge and a drug-targetable opportunity. We hypothesize that the viral integrase (IN) protein acts as a physical bridge between the gRNA and assembling capsid to guide correct localization of the genome. The proposed structural characterization and biochemical analysis will lead to greater understanding of the maturation process and identify for a novel target for anti-HIV drugs.